Role of HP1β-mediated heterochromatin organization in neurodevelopmental disorders: CBX1-related syndrome as a model

Project Summary/Abstract
An increasing number of neurodevelopmental disorders are causally linked to variants in genes encoding
chromatin proteins that regulate heterochromatin, transcriptionally silenced genomic regions. We recently
discovered one such diagnosis, CBX1-related syndrome, characterized by developmental disabilities, hypotonia,
and autistic features. This syndrome is caused by heterozygous variants in the CBX1 gene, which encodes
heterochromatin protein 1 beta (HP1β), a core structural protein of heterochromatin. The patient-identified
variants are all missense within a genomic region encoding a known functional domain of HP1β. The molecular
mechanism of CBX1-related syndrome remains to be determined, although our previous publication suggested
dominant-negative effects of the mutant HP1β. The predominance of neurological manifestations in individuals
with CBX1 variants suggests the important role of HP1β in neuronal gene regulation, but the function of HP1β in
brain tissue remains elusive. To investigate the mechanisms underlying CBX1-related syndrome, we created
mouse lines with patient-identified CBX1 variants. Heterozygous Cbx1 mutant mice show behavioral
abnormalities that suggest delayed neurotransmission. RNA sequencing of Cbx1 mutant mouse brain tissue
revealed increased expression of genes regulating synaptic function. These models and preliminary data provide
an opportunity to explore the mechanisms linking CBX1 variants to neuropathology. The overall objective of this
study is to elucidate the mechanisms of HP1β-mediated heterochromatin regulation and the impact of patient-
identified CBX1 variants in mouse models of CBX1-related syndrome. The rationale for this project is that
elucidating the impact of the patient-identified CBX1 variants will pave the way toward identifying potential
therapeutic approaches for CBX1-related syndrome, because elimination of mutant HP1β could ameliorate
cellular dysfunction if its effects were dominant-negative. The central hypothesis is that HP1β variants seen in
human patients interfere with neurodevelopment by increasing expression of genes within heterochromatin
through a dominant-negative mechanism. This hypothesis will be tested by comparing
transcriptomic/epigenomic and neurobehavioral phenotypes among mice with Cbx1 missense and loss-of-
function variants and wild-type mice. The knowledge gained from the proposed studies will have a positive impact
on the molecular mechanistic understanding of not only CBX1-related syndrome but also neurodevelopmental
disorders caused by heterochromatin dysfunction in general. This work will enable me to obtain training in
utilizing mouse models of neurodevelopmental disorders, in collaboration with leading experts. The completion
of this project will provide me with the skills and experimental data required for an R01 application. The training
available through this K02 award represents an essential component toward the attainment of my long-term goal
of studying the molecular mechanisms underlying the neurodevelopmental symptoms seen in CBX1-related
syndrome and other neurodevelopmental disorders caused by heterochromatin dysfunction.

Public health relevance
Project Narrative Neurodevelopmental disorders are major health problems, and while genetic contributions have been well established, their molecular mechanisms are still poorly understood. The proposed research is relevant to public health because it will address the mechanism of neurodevelopmental symptoms observed in individuals with CBX1-related syndrome. The proposed studies will provide novel mechanistic insights into the pathogenesis of neurodevelopmental disorders in general.